The confluence of extreme heat and cold on aging and longevity

About ten percent of Americans older than 65 (5.8 million) are estimated to live with Alzheimer’s dementia (AD) or related dementias (ADRD), constituting the 5th leading cause of death among 65 and older in the U.S. Yet, our estimates from the prevalence of AD/ADRD outdated and the vulnerabilities of the older adults living with AD/ADRD to extreme environmental change remain unknown. Understanding the vulnerabilities of these populations is critical due to two of the most prominent upcoming global challenges: a growing aging population and a increasing extreme weather events. On the one hand, the number of Americans ages 65 and older is projected to nearly double, while those with AD/ADRD are projected to nearly triple by 2050. On the other hand, the severity and frequency of the extreme environmental changes, such as extreme heat and cold events, are expected to increase. Extreme heat/cold events can increase mortality and healthcare utilization outcomes (e.g., hospitalization) among older adults. More frequent and intense extreme heat and cold events can pose disproportionate risks to the elderly population living with AD/ADRD through certain cognitive biologic pathways. However, we do not know about potential pathways through which exposure to extreme changes in ambient temperature may directly (or indirectly through other stressors) impact older AD/ADRD patients, whose responses to extreme environmental change may be disrupted/delayed due to memory loss, challenges in planning and solving problems, trouble in understanding visual images, and confusion with time and place. Our goal is to characterize the extent of the exacerbation of cause-specific healthcare utilization outcomes (i.e., hospitalizations, hospital readmissions within 30 days, primary care visits, and specialist visits) and mortality due to extreme heat/cold events, among the older adults living with AD/ADRD. Using a longitudinal cohort of over 63 million Medicare enrollees (65 years), we will apply comprehensive and well-validated computational approaches to study the immediate, short-, and long-term effects of extreme heat and cold events on healthcare utilization outcomes and mortality. In Aim 1, we will develop and validate computational methodologies to improve misclassification in AD/ADRD cohort identification, estimate and project the prevalence of the older adults living with dementia, build high-resolution spatio-temporal maps of extreme heat and cold events that can be integrated with administrative data (Aim 1c). In Aim 2, we will estimate the immediate and short-term effects of extreme heat and cold events on mortality and hospitalization (admission and emergency department visits) among the elderly population with AD/ADRD. Aim 3 will entail developing and deploying a high-performance computing pipeline to discover de novo and/or unanticipated causal links between long-term exposure to extreme temperature events and cause-specific healthcare utilization outcomes among older adults living with Alzheimer’s or related dementias.

Public health relevance
This study, in response to NIA PAR-19-070, will provide evidence regarding the immediate, short-, and long-term effects of exposure to extreme heat or cold weather events on the health and livelihood of American seniors living with Alzheimer’s disease or Alzheimer's disease-related dementia. The methods, tools, and findings of our project will enhance identifying and predicting vulnerable populations and facilitate investing in pathways to mitigate the negative consequences of extreme heat/cold events on the older AD/ADRD patient populations.